Admin Core

PROJECT SUMMARY
The goals of the Administrative Core are to facilitate implementation of the overall vision of this SPORE
and its constituent projects, cores and programs. This work will be carried out by a governing body
comprised of the SPORE leadership and key members of the DF/HCC. Both Dr. Sequist and Dr. Barbie
are highly qualified co-directors of the Lung SPORE Program with a strong track-record of research
productivity in translational and laboratory-based investigation. In addition to the talented team of Lung
Cancer SPORE investigators, they have further assembled a well-qualified Governance Committee,
Patient Advocacy Committee, Internal and External Advisory Boards, and Project and Grants
Administrators to support them in this endeavor. Among other tasks, this will include oversight and
monitoring of research progress, facilitation of collaborations, and development of a flexible research
program that ensures maximum translational focus. In addition, they have secured substantial
additional institutional resources to supplement the proposed research, both covering the costs of
expensive novel technologies and supporting additional Career Enhancement and Developmental
Research Program Grants. The overall purpose of the Administrative Core is thus to coordinate and
operationalize all of the individual components of the DF/HCC Lung Cancer SPORE Program and to
provide administrative and fiscal oversight.